Inhibiting secondary structure formation in long single-stranded DNA

The diversification of the health-related work force is a crucial component of not only increasing inclusiveness, but also opening up the field to a more diverse set of perspectives. Aim 1 : This supplement is aimed at increasing research experience of a Latina candidate while having her study for, apply to, and be admitted to medical school. One of the greatest challenges of biotechnology is establishing the base sequence of individual molecules of DNA without the need for PCR or other amplification. The read length, in particular, is an important factor in being able to sequence accurately. Aim 2 : We aim to study methods to increase the read length by inhibiting secondary structure formation in single-stranded DNA.

Public health relevance
The ability to sequence a single DNA molecule completely by simply reading its bases is a grand challenge in biotechnology. Several techniques are aiming to meet that challenge, but there are fundamental limits to how close they may be able to get. Here, we propose to study how to increase the length of DNA segments that can be sequenced.